The effects of ovulation on fallopian tube-derived tumorigenesis using microfluidic PREDICT-MOS platform

Project Summary/Abstract
High grade serous ovarian cancer (HGSOC) is the most prevalent and lethal histotype of ovarian cancer. The
fallopian tube is the primary origin of most HGSOCs, supported by evidence from molecular analysis and
clinically demonstrated by the protective effect of salpingectomy. Ovulation is a major risk factor for ovarian
cancer. Currently, the only means for prevention are through the reduction of lifetime ovulatory events, such as
through the use hormonal birth control or surgical removal of the fallopian tubes and ovaries. The complexity in
understanding the dynamic interplay between ovarian secretions and fallopian tube epithelium (FTE) is
compounded by the deep-seated abdominal location and the elusive dispersion of fluids secreted by the ovary
into the peritoneal space. Therefore, the molecular mechanisms that drive the initiation of ovarian cancer in the
fallopian tube in response to ovulation are poorly understood. To address these challenges, our collaborative
team has developed a physiologically accurate menstrual cycle model using the PREDICT Multi-Organ System
(MOS), a microfluidic (organ-on-chip) device that enables us to recapitulate the process of ovulation and capture
the entirety of ovarian secretions. Additionally, our lab engineered preneoplastic murine oviductal epithelial
(MOE) cell models (equivalent to the human fallopian tube) that express the most commonly and earliest
identified aberrations in HGSOC: Pax2 loss and p53 mutation (R2723H). Utilizing ovulation secretions captured
on the platform, we observed an upregulation of DNA damage response transcripts in the fallopian tube models,
followed by an increase in proliferation caused by secretions from the luteal phase in our Pax2 deficient cells.
These findings are significant, as they demonstrate that ovarian secretions induce DNA damage and proliferation
in the FTE. Our proposed aims encompass understanding the pathways associated with DNA damage, oxidative
stress, and cell migration caused by ovulation as well as uncovering the molecular pathways that drive FTE
proliferation in the luteal phase. Additionally, we will investigate the in vitro efficacy of a Cox2 inhibitor to act as
a potential chemopreventative agent and to mitigate the damaging effects of ovulation. With increasing interest
in non-hormonal birth control methods, our proposal represents a step towards investigating a non-hormonal
strategy for prevention. Through the experiments outlined in this proposal, we aim to identify the early
mechanisms involved in HGSOC initiation by studying phase-dependent changes caused by secretions from the
ovary. The research project and strategies will facilitate my training as a PharmD/PhD student given their focus
on uncovering mechanisms and treatments for HGSOC.

Public health relevance
Project Narrative High grade serous ovarian cancer (HGSOC) has a dismal prognosis, largely attributed poor detection methods and lack of preventive strategies. Understanding the mechanisms underlying HGSOC development is crucial to identify early intervention strategies, especially for high-risk patients. In this proposal, we outline a series of experiments exploring the relationship between ovulation and fallopian tube derived tumorigenesis using a microfluidic device in hopes of developing a new strategy to prevent or delay the development of HGSOC, ultimately improving clinical outcomes.